Epigenetic regulation in cardiac development

Project Summary/ Abstract
The development of heart is a complicated developmental process that requires precise and coordinated spatial
and temporal regulation in gene transcription. Epigenetic factors, such as the Ten-eleven Translocation (TET)
family of dioxygenase that catalyzes 5-methyocytosine (5mC) oxidation, play indispensable roles in orchestrating
the cardiac transcription network during normal heart development. Tet depletion has been shown by others and
us to block the differentiation of embryonic stem cells toward cardiac progenitor ex vivo. The team has further
established that cardiac specific Tet deletion could result in noncompaction cardiomyopathy (NCC) due to
dysregulation of chromatin accessibility and impaired long-range enhancer-promoter looping that disrupts the
transcription of genes important for cardiac development. More recently, the team further discovered that Tet
deficient embryonic heart tissues exhibited abnormal expression of genes that are important for lipid metabolism,
which might also count for developmental defects observed in cardiac specific Tet-deficient mouse models.
Despite the knowledges obtained from these studies, two outstanding questions remain unresolved: (i) how Tet
proteins acquire their specificity to precisely regulate lineage-specific enhancers; and (ii) whether and how
prenatal maternal metabolic stressors influence TET-related epigenetic pathways and impact cardiac
development in the progeny. In this research program, the PI will use both unique genetically modified mouse
models and human embryonic stem cells differentiated toward the cardiac lineage to address these questions.
In project 1, the team will investigate the pathogenic mechanisms regarding how newly discovered TET2
mutations in patients with congenital heart diseases (CHD) impair heart development and cardiac lineage
specification. In project 2, the team will unravel molecular mechanisms undergirding TET-mediated enhancer
recognition specificity during heart development. In project 3, the team will illuminate how prenatal maternal high
fat diet as a stressor effects Tet mediated epigenetic regulation to perturb cardiac development. From a
translational perspective, we will test the use of vitamin C to boost Tet activity and reduce the risk of
developmental defects related to maternal high fat-diet exposure. The proposed fundamental studies are
necessary to promote healthy cardiac development and illuminate previously underappreciated mechanisms
underpinning CHDs and cardiovascular diseases. This proposal will also lend insight into how external
metabolites influence epigenetic landscapes during heart development and how metabolic factors can be
harnessed to rectify epigenetic abnormalities to restore normal cardiac development.

Public health relevance
PROJECT NARRATIVE This project is tightly aligned with the NIH mission by unveiling new epigenetic mechanisms that account for the embryonic heart development, with a focus on the DNA methylation homeostasis and maternal metabolic influence. Our studies will furnish important insights that are immediately relevant to the precise temporal and spatial epigenetic regulation which contributes to the normal heart development. Our discoveries will significantly promote healthy cardiac development and illuminate previously underappreciated epigenetic mechanisms underpinning congenital cardiovascular diseases and cardiovascular diseases.